Sex Differences Administrative Support Core

Core A: Sex Differences Administrative Support Core will be responsible for the following five services to coordinate the three projects in this SCOR. Aim 1: Administration: Core A will provide administrative support to Projects 1,11, and 111 for recruitment. subject scheduling, forms generation, IRB issues, organization, and confidential filing. Centralized support will decrease cost and increase effectiveness. Aim 2: Human Subjects: Core A will assure ongoing safety of human subjects through active involvement with our IRB committee. This involvement will assure compliance with institutional and national regulations, track and assess subject safety by monitoring adverse events, and provide information to outside subject safety committee (DSMB) as necessary. This core will prepare regular reports from centralized logs from all Projects concerning adverse events to increase detection of infrequent events that require special attention. Aim 3: Fostering Sex and Gender Research: Core A will seek to stimulate further research with the following activities: a) convene an annual SCOR sponsored Pelvic Floor Research Day to foster interdisciplinary discussion across campus along with translational partners and mentees, and b) support, maintain, and expand the SCOR Pelvic Floor Disorders Data Bank of over 1,200 research subjects, totaling over 20,000 images from prior and ongoing projects. Aim 4: Budget: Core A will manage the fiscal responsibility of Project I, II, and III along with expenses of Cores A, B, and C. This will include assurance of appropriate distribution of funds to support all three projects throughout the entire length of the funding period. Aim 5: Presentation and Manuscript Production: Core A will be responsible for the administrative aspects of the dissemination of data and findings to research and clinical practitioners. Manuscripts and presentations will be submitted and tracked through Core A, allowing immediate translation of important sex-differences research to the community of researchers and physicians who can implement changes and improve prevention and treatment.

Public health relevance
RELEVANCE (See instructions): The strong central organizing activities of this administrative core will facilitate new discoveries that impact interdisciplinary sex-differences research. By promoting and supporting the broadly interdisciplinary U-M SCOR research team, Core A frees individual investigators from some management effort so they may concentrate on important insights needed to improve prevention and treatment for 3 million women giving birth and 300,000 women suffering from pelvic floor disorders.